Neural Basis of Language in Acute Stroke and Recovery

Language deficits after stroke resolve to different degrees across individuals. In previous funding cycles we
have characterized distinct mechanisms of recovery, including restoration of blood flow to dysfunctional brain
tissue surrounding the infarct and reorganization of networks (brain regions or their connections) underlying
specific language functions. We have previously focused on mechanisms of recovery of naming and spoken
word comprehension. Here we propose to characterize mechanisms of recovery of discourse comprehension,
reading, and spelling (functions that are increasingly critical in a society dependent on internet use such as
online banking and shopping, email, texting, and so on) in each individual with aphasia over the course of one
year. In addition, we will evaluate the use of compensation by learning to accomplish the function in a different
way or using different modalities to communicate, as another mechanism of recovery. We will use longitudinal
structural and perfusion imaging, along with functional Near Infrared Spectroscopy (fNIRS) and language
assessments twice within 10 days of stroke onset (once before and once after intervention to restore blood
flow or 3 days after initial testing in cases of no intervention) and again at 3 months, 6 months, and 12 months
after acute left hemisphere ischemic stroke. Furthermore, we propose to identify variables that predict
recovery through each mechanism. We will determine which demographic, imaging, and genetic factors
influence the success of each mechanism. Results will allow clinicians to focus treatment strategies on the
mechanisms most likely to be successful for an individual. Thus, the brain imaging and behavioral data
together will help us achieve another important clinical goal, aligned with the mission of NIDCD, to improve
prognosis for aphasia recovery at an individual level. Identifying lesion and brain health characteristics,
polymorphisms of the Brain Derived Neurotrophic Factor allele, selective serotonin receptor antagonists
(SSRIs), demographic factors, pre-stroke written language use information, and use of compensatory
strategies that independently contribute to aphasia recovery will allow us to better predict who is likely to
achieve the greatest recovery and under what conditions. These results will also provide the critical basis for
individualized aphasia rehabilitation. We will test our hypotheses in a racially and socioeconomically diverse
population of people with post-stroke aphasia, which is essential to allow generalization of findings to improve
management of a wide range of people with aphasia (PWA).

Public health relevance
Post-stroke language deficits are exceedingly common and can be devastating to social relationships, vocational success, and independence in activities such as shopping, banking, texting, and emailing. We will characterize how language deficits resolve or improve over the first year after left hemisphere stroke, by carrying out longitudinal language assessments and brain imaging. We aim to identify demographic, genetic, and imaging variables that predict improvement in discourse comprehension, reading, spelling through (1) restoration of blood flow to brain specific regions, (2) repurposing of healthy brain areas to take over functions of areas damaged by stroke, or (3) development of compensatory strategies.